Development of a MMP Inhibitor for Neuropathic Pain

? DESCRIPTION (provided by applicant): Aquilus Pharmaceuticals, Inc. proposes to preclinically develop AQU-118 for the treatment of orofacial and general neuropathic pain via a newly discovered mechanism involving matrix metalloproteinases-2 & 9 (MMP-2, MMP-9). AQU-118 is a non-hydroxamic acid containing, MMP inhibitor that is selective for both MMP-2 and MMP-9 and has been shown to block mechanical allodynia in both the spinal nerve ligation (SNL) and the chronic constriction injury of the infraorbital nerve (CCI-IoN) rodent models of neuropathic pain. The goals for Phase II are to scale-up the synthesis of AQU-118, determine its phamacokinetics & phamacodynamics (PK/PD) in the SNL-rat model and complete in-vitro safety studies within the first year. Year two will entail the process research & development (PRD) of the synthetic scale- up of AQU-118 culminating in its GMP manufacture as well completing various pivotol GLP animal toxicity studies. The ultimate goal of the proposed work is to rapidly develop a safe and effective drug for the treatment of chronic orofacial and general neuropathic pain that produces no addictive or euphoric side-effects.

Public health relevance
PUBLIC HEALTH RELEVANCE: Millions of Americans suffer from chronic neuropathic pain for which no current single drug treatment is effective in more than 50% of patients. Of those drugs that are effective their side effect profile and/or propensity for addiction make them poor candidates for long-term use. Aquilus Pharmaceuticals plans to develop a compound that has been found to block neuropathic pain in various animal models via a newly discovered pain pathway. The purpose of the proposed work is to further study this new compound and determine whether it is safe enough and can be made in sufficient quantities to be tested in humans. If the project is successful, Aquilus Pharmaceuticals will be able to bring to the clinic a pain drug with a novel mechanism of action that would be focused on the treatment of chronic orofacial and general neuropathic pain without producing any addictive or euphoric side effects.